Core 2 - Clinical and Tissue Core

Project Summary – Core 2 – Clinical and Tissue Core CHU-Toulouse / DFCI
Modern biomedical research is being transformed by what is increasingly becoming a flood of information.
Electronic medical records have opened unprecedented opportunities for studies investigating a wide range of
problems ranging from epidemiological aspects of human disease to the comparative effectiveness of various
treatment protocols. Similarly, genomic technologies such as next-generation DNA and RNA sequencing from
bulk and single cell have opened a floodgate of data and information that promises to shed light on the complex
nature of human disease. In this information-rich age, one of the greatest challenges is therefore no longer
generating data, but effectively integrating it so that it can be used to our advantage. Because clinical practice
has long been separate from the research enterprise at most academic health centers, a situation has evolved
in which clinical and research data exist in separate, often incompatible domains with a variety of technical,
institutional, and organizational barriers between them. Further limiting our ability to extract the maximal value
of the data we have available is the fact that data within institutions is rarely integrated with the vast body of data
available in the public domain. Similarly, another need is to aid Investigators better characterize and identify
tumor biologic and molecular genetic correlates for response, progression, and survival by collecting, preserving
and distributing tissue derived from patients on clinical protocol. A large sources of clinical data will be used in
this program project. The data for this large IFM/DFCI collaborative clinical trials are collected in an established
clinical trials database at the IFM and DFCI. In the previous funding period this core has supported number of
clinical publications by providing database support and help projects generate large volume of genomics data
by providing quality-controlled tissue sample. This Core will continue to have as its main goals to create,
maintain, and quality control the clinical database (Specific Aim 1); and to collect, transport, process and store
tissue samples from all sites utilizing standardized procedures in centralized tissue banks (Specific Aim 2); and
to develop an integrated database to incorporate the sample tracking and oncogenomic information with the
relevant clinical data from the clinical trials database with web based query capabilities (Specific Aim 3).

Public health relevance
Project Narrative – Core 2 – Clinical and Tissue Core CHU-Toulouse / DFCI This core will help collect data, procure, process and store tissue samples and develop a integrated database to collect and store data from various sources.